HIVIG FOR THE PREVENTION OF MATERNAL-FETAL HIV TRANSMISSION

This study will evaluate the effect of combination therapy with Hyperimmune Anti-HIV Intravenous Immunoglobulin (HIVIG) and ZDV compared to IVIG and ZVD administered similarly, on the incidence of HIV infection in infants born to HIV-infected women who are receiving ZVD for medical indications. (ACTG 185)